ORAL GI262570X IN PATIENTS W/ TYPE 2 DIABETES MELLITUS

The primary objective of this study is to test the safety and efficacy of GI262570X Soft-Gelatin Capsules for the treatment of Type 2 Diabetes Mellitus and to determine the appropriate dosing for future development.